Optimization and Preclinical Validation of QTE Therapy for Friedreich's Ataxia

ABSTRACT
Friedreich's ataxia (FRDA), the most prevalent inherited ataxia, causes debilitating neurodegeneration and
cardiac issues, typically leading to mortality by age 35. Current treatments, including the FDA-approved
omaveloxolone, offer limited efficacy and present notable side effects. We propose an innovative approach with
QTE therapy, targeting the underlying molecular mechanisms of FRDA. Our initial studies have shown that QTE
therapy modulates important FRDA target protein levels, improves cardiac function, mitigates iron overload, and
significantly increases survival rates in FRDAkd mice, outperforming existing treatments. In Aim 1 of this project,
we focus on optimizing the QTE dosage and formulation through Physiologically-Based Pharmacokinetic (PBPK)
modeling, assessing drug synergy, bioavailability, and blood-brain barrier penetration. In Aim 2, we will evaluate
the optimized dosage’s efficacy in reversing behavioral and pathological deficits in FRDAkd mice, using
comprehensive neurological and cardiac assessments. We aim to demonstrate significant improvements in
cardiac function and neurological health, surpassing current treatment benchmarks. Our team is well-equipped
to transition QTE therapy from preclinical research to clinical trials. In this project, we will focus on dosage and
formulation optimization through PBPK modeling and conduct comprehensive efficacy testing in FRDAkd mice.
For the next phase, we will collaborate with regulatory strategy experts, drug manufacturing specialists,
formulation and packaging experts, and clinical trial professionals. This will guide us toward IND submission and
the initiation of clinical trials. Our commercial strategy will be developed in partnership with a patient advocacy
group to leverage orphan drug benefits, promote community engagement, and establish alliances with firms
experienced in rare diseases. This approach is designed to streamline the market entry and distribution of QTE
therapy, offering a novel, effective, and safer treatment alternative for FRDA patients.

Public health relevance
PROJECT NARRATIVE Friedreich's ataxia (FRDA), the most common inherited ataxia, causes severe neurodegeneration and heart issues, often leading to early death by age 35. Existing treatments, with limited efficacy and notable side effects, underscore the need for safer, more effective FRDA therapies. Our safe and innovative QTE therapy demonstrates promise in preclinical studies, improving survival, cardiac function, and reducing iron overload in FRDA models, suggesting a potentially efficient and safer treatment option.